Local Sustained Delivery of Osteoprotegerin via Hydroxyapatite Microparticles to Enhance Post-Orthodontic Tooth Stability

PROJECT SUMMARY/ABSTRACT
Post-treatment relapse is one of the most unpredictable limitations of orthodontic therapy. Relapse results in
patient's teeth reverting towards their pretreatment positions, which increases the susceptibility to functional
problems, dental disease, and substantially increases the financial burden for retreatment. Currently, patient
compliance-based retention is the primary method for maintaining post-orthodontic tooth stability, which due to
its variable use results in a significant proportion of patients experiencing relapse. Therefore, the objective of
this application is to address the clinical need for a translational and clinically relevant approach to increase
post-orthodontic tooth stability using approaches that minimize the need for patient compliance. Orthodontic
relapse is strongly associated with increased bone-resorbing osteoclast activity and immature bone quality
surrounding the teeth. As such, a promising approach to this adverse outcome is to produce a response of net
bone accretion by synergistically inducing osteogenesis and inhibiting osteoclastic activity. However, a strategy
to produce such synergistic responses in bone has never been explored for this purpose. Our group has found
that multiple and single submucosal injections of anti-osteoclastic recombinant OPG protein (OPG-Fc) reduced
relapse by 60-70% in a rat model of orthodontic relapse. These biological methods have not been adopted for
clinical use presumably due to the lack of effective drug delivery systems that mitigate the need for large bolus
doses over long durations that may produce systemic effects. This application aims to develop a clinically
relevant osteoconductive hydroxyapatite (HAP)-based drug delivery system for local and sustained release of
OPG to mitigate post-orthodontic relapse that will also enhance our understanding of bone
regeneration/maturation following mechanically mediated bone turnover through modulation of these
responses by HAP and OPG.
This project will test the central hypothesis that sustained release of recombinant OPG from hollow
hydroxyapatite (HHAP) microparticles will inhibit orthodontic relapse by decreasing osteolysis and promoting
bone anabolism. Aim 1 will build on our preliminary data to engineer HHAP microparticles for sustained release
of OPG at desired concentrations and validate this system in vitro with OPG and osteoclast activity assays. Aim
2 will validate the use of OPG administered for local and sustained release via HHAP drug delivery microparticles
to mitigate relapse in our animal model of orthodontic relapse with minimal systemic effects. Furthermore, this
study will characterize potential molecular pathways by which the periodontal tissues and cellular responses
result in enhancing bone regeneration and maturation. The successful completion of this project will lead to a
translatable method to improve post-orthodontic tooth stability outcomes and provide significant insight into
enhancing bone regeneration/maturation following mechanically mediated bone turnover.

Public health relevance
PROJECT NARRATIVE Orthodontic relapse is one of the most challenging and ubiquitous problems in the field that leads to negative treatment outcomes for orofacial aesthetics, oral functions, and increases the risk of dental disease as well as the health care cost burden. Biologic therapies that mitigate this response have shown promise in animal models, but the lack of appropriate drug delivery systems has precluded their translation. The experiments outlined in this application will elucidate the use of anti-osteoclastic OPG administered for local and sustained release via an osteoconductive hydroxyapatite drug delivery system to mitigate relapse.